Core E: Chemistry and Analytical Core (CAC)

ABSTRACT: CHEMISTRY AND ANALYICAL CORE
The Chemistry and Analytical Core (CAC) is a critical research support core for the UNC-SRP, providing
expertise and analytical capabilities to measure toxic substances with prioritization of inorganic arsenic (iAs) and
co-occurring contaminants and characterize their effects on metabolic dysfunction/diabetes. The CAC offers
analytical expertise and services, access to state-of-the-art instrumentation for metals measurements,
microbiome and metabolomics analysis, and training in cutting-edge research methodologies. The CAC provides
Projects 1-4 with the tools and expertise needed to generate critical data sets that will help to identify novel
strategies to reduce iAs exposure and to prevent iAs-induced metabolic dysfunction. The CAC staff
accomplishes tasks through utilization of an ultra-sensitive Agilent 8900 triple quadrupole inductively coupled
plasma mass spectrometry (ICP-MS) and an Agilent 7900-based hydride generation-cryotrapping-ICP-MS (HG-
CT-ICP-MS) for total element and speciation analysis, and high resolution Thermo QE HF Orbitrap MS systems
for metabolomics profiling and metabolite identification. In addition, the CAC has established expertise in
microbiome analysis via 16S rRNA gene sequencing and shotgun metagenomics using the MiSeq and NovaSeq
platforms. The overall objective of the CAC is to provide the UNC-SRP Projects with analytical infrastructure,
instrumentation, service, training and related support in data interpretation. Three specific aims will be pursued,
including: Aim 1. Establish and implement state-of-art analytical methodologies to enable sensitive, accurate and
precise measurement of trace metals for all UNC Superfund Projects; Aim 2. Leverage analytical expertise in
microbiome and metabolomics to support mechanistic studies and the development of tangible solutions to
mediate iAs toxicity; and Aim 3. Provide consultation to Biomedical and Environmental Science Projects and
extensive training for graduate students and postdoctoral trainees on instrumentation and data interpretation.
The CAC supports the overall theme of the UNC-SRP: “Protecting vulnerable populations from arsenic-induced
metabolic dysfunction with a vision for exposure reduction and disease prevention.” The CAC will provide critical
research support for the UNC-SRP and serve as an integral part of the success of the research within the UNC-
SRP. The CAC activities promote interactions among all Projects and Cores through expertise in metals
analyses, microbiome and metabolomics analyses. With every component in place, including state-of-the-art
equipment, rigorous QA/QC plans, highly experienced personnel, strong leadership team and institutional
support, the CAC will play a key role in forging links among the researchers of the UNC-SRP and beyond.

Public health relevance
NARRATIVE: CHEMISTRY AND ANALYTICAL CORE The overarching goal of Chemistry and Analytical Core (CAC) is to develop and apply ultra-sensitive and specific analytical methods to measure metals (iAs, its species and other co-occurring contaminants) in environmental and biological samples and characterize toxicant-induced adverse health effects via microbiome and metabolomics approaches. These data provide critical research support for all UNC-SRP projects and promote the integration of the UNC-SRP to better understand and protect the public from adverse health effects related to Superfund chemicals.